Core B-Omics and Gene-Editing

Core B-Abstract
The goal of the Molecular Center of Health and Disease (MCHD) is to facilitate research under a central theme
of molecular physiology to enhance the depth of education, mentorship, and training of researchers to apply
omics technology and computational biology across the health-disease continuum. An understanding of genetic
susceptibility and molecular mechanisms involved in onset and progression of disease has the potential to lead
to early interventions as well as novel therapeutic targets. The integration of genomic, transcriptomic, proteomic,
and metabolomic datasets along with physiological information using computational approaches can provide
novel insight into the molecular, cellular, and overall physiology associated with the health-disease continuum.
The mission of the MCHD will be achieved through synergistic interaction across multiple components, including
Core A (including administrative oversight, education and mentoring programs, and a pilot project program), two
research cores, and three major project investigators, to address diverse questions of health and disease using
molecular and computational approaches. In particular, Core B- Omics and Gene-Editing will provide
researchers access to a comprehensive state-of-the-art omics data collection pipelines, mechanistic gene-
editing and biological approaches, and seamless integration with the Research Computing, Bioinformatics, and
Biostatistics Core (Core C) will provide greater depth and insight into biological processes associated with major
project and pilot program researcher scientific questions. Core B will enhance current infrastructure, including
by implementing new high-throughput sequencing methods, such as spatial transcriptomics and new equipment
for long-read sequencing and structural variation as well as the development of a new and innovative capability
involving CRISPR/Cas9 gene-editing technology to interrogate gene function and biological pathways. The
objectives of Core B are: (1) promote education and training of faculty, trainees, and students in omics
technologies and gene-editing technologies; (2) provide MCHD investigators access to technical expertise and
cutting-edge omics services, including next generation sequencing methodologies and mass spectrometry
targeted proteomics and metabolomics; (3) provide MCHD investigators access to advanced gene-editing and
viral vector development to investigate gene function and pathways associated with researcher initiated scientific
questions; and (4) seek continuous improvement in existing assays, services, and enhance technological
capabilities through acquisition of new cutting-edge instrumentation that will assist in the sustainability of the
Core. In total, these aims will work in synergy with junior researchers to provide an innovative, state-of-the-art
infrastructure to enhance and strengthen investigation into the molecular underpinnings of health and disease,
bolster success in extramural research funding, and collaboratively grow the MCHD.